Research to Advance Connected and Community Health Equity (ReACH Equity)

Project Summary: The UC Davis REsearch to Advance Connected and Community Health Equity (ReACH
Equity) Predoctoral Training Program Plan
The UC Davis ReACH Equity predoctoral training program responds to NINR’s call to action to address the
impacts of societal inequities in health and healthcare by training a new generation of scientists to employ
advanced, multidisciplinary, multi-level methods to improve health equity. We will provide a rich training
environment for 26 predoctoral trainees to establish the evidence base for improving health equity across the
lifespan among historically and presently marginalized communities (HMCs) through research at the
systemic/policy, community/services, and family/individual levels. The objectives are to: 1) recruit and retain a
diverse group of predoctoral trainees who conduct rigorous, innovative, equity-focused research in prevention
science and population health; 2) empower ReACH Equity trainees to make informed decisions about the
breadth of research-focused career paths, including academia, public policy, and industry; and 3) educate
trainees in multidisciplinary approaches to equity-focused prevention science and population health, including
core doctoral competencies (e.g., conceptual knowledge, developing important research questions, community
engagement, all facets of study design, implementation, evaluation, and dissemination, and professional
development). These objectives are accomplished in a carefully structured program that leverages the
expertise of 50 mentors, the majority of whom are underrepresented in science, from 17 individual
Departments in three Colleges, the Betty Irene Moore School of Nursing, and the School of Medicine on both
our Sacramento and Davis campuses. These mentors’ expertise cuts across the disciplinary spectra (e.g.,
nursing science, human development, psychology, sociology, nutrition, computer science, public health
sciences, health policy), focuses on a wide variety of HMC populations, and addresses inequities from prenatal
populations through older adults. We will use the peer-onsite-distance model of mentoring, where trainees will
be matched to a primary mentorship team that includes one experienced mentor and one mentor-in-training;
this team will serve as their content experts. Each cohort also will have a cohort mentor to facilitate group and
peer mentoring. Trainees will engage in didactic and experiential learning that will provide them with the core
competencies and in-depth theoretical knowledge required for successful careers in health equity by ensuring
that advances in equity-focused prevention science and population health are utilized among HMCs. We will
engage in continuous quality improvement through ongoing internal evaluation of processes and outcomes, as
well as reviews from an external advisory board and a local community advisory board comprised of patients
and families. The disciplinary diversity combined with expertise mentoring individuals from HMCs among our
pool of mentors will support trainees to invoke research questions that enable collaboration with a
multidisciplinary team of investigators to elucidate the complex interplay of factors that contribute to health
inequities, and then to use multiple perspectives and methodologies to identify sustainable solutions.

Public health relevance
Project Narrative: The UC Davis REsearch to Advance Connected and Community Health Equity (ReACH Equity) Predoctoral Training Program Plan The UC Davis ReACH Equity predoctoral training program will leverage UC Davis’s strengths in nursing, social, behavioral, and biomedical sciences, its proximity to the CA state legislature, the varied historically and presently marginalized communities (HMCs) it serves, and the robust community partnerships it has developed over time to provide a rich training environment for a diverse group of 26 trainees to solve the nation’s pressing health problems and persistent health challenges. Through direct instruction, experiential learning, and mentored research, trainees will gain knowledge and skills that will prepare them for future research careers in academia, public policy, and industry aimed at ensuring advances in equity-focused prevention science and population health are utilized among HMCs. Continuous evaluation of our program will affirm that we accomplish the aims of this training program and successfully train the next generation of health equity researchers.